Aging, macrophage mediators, and burn trauma: Supplement

Project Summary/Abstract
Alzheimer's Disease (AD) and AD related disorders (ADRD) affect millions of people in the United States and
are major contributors to dementia worldwide. Since neuroinflammation plays an integral role in AD/ADRD, we
propose to expand our long-term NIA-funded research (R01 AG018859-19) to gain new knowledge about how
advanced age and the gut-brain axis trigger the decline in cognitive function using our well-established
clinically relevant murine model of cutaneous burn injury. Clinical and experimental evidence reveal that
healthy aged subjects are in an elevated basal inflammatory state, referred to as “inflamm-aging,” which can
contribute to deficits in tissue injury and repair. We, and others, believe that inflammaging is caused, in part, by
translocation of bacterial products from the intestinal lumen and that exposure to these products triggers the
production of pro-inflammatory cytokines and chemokines, including tumor necrosis factor alpha (TNF),
interleukin (IL)-1β, IL-6, and C-C Motif Chemokine Ligand 2 (CCL2). Recently published work from our lab
revealed that aged mice who sustain a scald burn injury have a greater breach in intestinal epithelial barrier
integrity than younger mice given the same injury. Additionally, we found that this heightened intestinal
response, and an alteration in the intestinal microbiome, both parallel a profound rise in inflammatory markers
in the brain. Both neuroinflammation and burn injury in the aged population have been correlated with
breaches in the blood brain barrier (BBB), delirium, and other signs of cognitive decline. From these
observations, we hypothesize that increased gut leakiness and altered intestinal microbiome in aged
mice after burn injury leads to heightened systemic inflammation and breach of the BBB, neuronal
damage, and cognitive decline. To test this, we propose to examine BBB dysfunction, neuroinflammation
and cognitive function in young and aged mice after burn injury by comparing the integrity of the BBB, the
presence of gut-derived bacteria/lipopolysaccharide (LPS) in the brain, as well as the systemic circulation, and
characterizing the activation of microglia and neuronal damage/death following injury. Moreover, we will
monitor cognitive function in young and aged mice both before and after burn injury to allow us to correlate
these behavioral tests with the aforementioned biomarkers of leakiness, inflammation, and neuronal damage.
These studies will expand our understanding of how advanced age alters the gut in the context of burn injury
and the impact of intestinal permeability on neuroinflammation, a hallmark of AD/ADRD. It is our hope that this
work will lead to the development of novel therapies to treat the excessive inflammatory response and
cognitive dysfunction seen in older patients suffering from traumatic injuries and a variety of other disorders.

Public health relevance
Narrative Alzheimer's Disease (AD) and AD related disorders (ADRD) are progressive neurologic disorders primarily affecting the elderly. Damaging more than just the skin, burn injuries can lead to excessive inflammation that often involves multiple organs systems including leakiness of the protective barriers of the gut and the brain, leading to aberrant cognitive function including delirium and dementia, which may parallel the changes seen in AD/ADRD. By investigating age-related mechanisms responsible for early damage to the gut and blood brain barriers after burn injury, we hope to identify novel strategies to reduce the impact of this post-injury neuroinflammation and mental decline seen in elderly subjects suffering from a wide range of diseases, including AD/ADRD.